A Potent D-peptide Inhibitor of TNFα for Treatment of Rheumatoid Arthritis

Rheumatoid arthritis (RA) is a chronic, debilitating inflammatory disease with high medical and societal costs
afflicting more than 1.6 million Americans. Blockade of TNFα-driven inflammation with approved anti-TNFα
biologics (such as Humira®, Remicade®, Simponi®, and Enbrel®) is an effective treatment for many patients
suffering from RA. However, due at least in part to the immunogenicity of these anti-TNFα biologics, upwards of
50% of RA patients initially responding favorably to these agents later lose benefit due to anti-drug antibodies
(ADA).
We have designed a stable, protease-resistant anti-TNFα peptide, DBT178, with potential to overcome
treatment-limiting ADA. DBT178 is a highly potent and specific D-peptide discovered via mirror-image phage
display. DBT178 blocks both soluble and membrane-bound TNFα activity and is 6 - 400-fold more potent than
the leading anti-TNFα biologic, Humiraâ, in various in-vitro assays.
D-peptides are the chiral mirror images of natural L-peptides. Since enzymes exhibit chiral specificity, D-peptides
are essentially inert to proteolysis. As proteolytic degradation and surface display of peptide fragments on
antigen-presenting cells (APC) are critical steps in the generation of a productive immune response, the inherent
resistance to proteolysis renders D-peptides minimally immunogenic.
The goal of this 1-year SBIR grant is to demonstrate the efficacy of DBT178 in a validated disease model of RA.
Aim 1 seeks to evaluate the pharmacokinetics of systemic delivery of DBT178 via osmotic pumps in healthy
mice. Aim 2 applies the insights from Aim 1 to evaluate the systemic delivery of DBT178 in a chronic model of
spontaneous and progressive RA in transgenic mice overexpressing human TNFα. Aim 3 focuses on the
development of microsphere formulations which, following a single dose, would provide effective, sustained drug
levels of DBT178 for a period of one month or longer.
The development of a novel, disease-modifying anti-TNFα agent resistant to treatment-limiting ADA could greatly
benefit RA patients by increasing the duration of response. In addition to this potential clinical benefit, at
commercial scale, the projected production cost of DBT178 is anticipated to be one-tenth the cost of anti-TNFα
biologics. This benefit could lower overall treatment costs and greatly improve access to optimal treatment for
patients with RA.

Public health relevance
Rheumatoid arthritis is a debilitating, chronic inflammatory disease, though blockade of TNFα driven inflammation with anti-TNFα biologics is a highly effective treatment for many patients. Unfortunately, TNFα biologics are costly (currently >$68,000/year) and repeated administration of anti-TNFα biologics leads to loss of efficacy due, in part, to anti-drug antibodies. To address these limitations, we have developed a fully synthetic, protease resistant TNFα inhibitor with outstanding potency, designed to have minimal immunogenicity and 10% of the manufacturing cost compared to current anti-TNFα biologics.